Generation and Validation of a Novel Genome-Scale Inducible RNAi Library for Functional Genetics in Leishmania braziliensis.

Project Summary
Leishmania parasites cause a suite of devastating Neglected Tropical Diseases that afflict as many as
one million people per year. Genetic tools for understanding important questions in Leishmania biology are
currently quite limited. Most Leishmania species lack the capacity for RNA interference (RNAi), precluding the
implementation of genome-scale RNAi library screens like those that have revolutionized molecular genetics in
the related kinetoplastid T. brucei. However, the Viannia subgenus, which includes Leishmania braziliensis,
has retained the RNAi machinery. We have developed the first inducible RNAi system for L. braziliensis and
have adapted it for high throughput Loss-of-Function RNAi screens. The overall goal of this proposal is to
generate and validate a novel, genome-scale, inducible RNAi library in L. braziliensis that will serve as a
versatile new genetic tool for the field. Despite differences in the capacity for RNAi, the genome organization,
life cycle stages, and disease pathology of L. braziliensis are very similar to other Leishmania species, making
it likely that results from L. braziliensis RNAi screens will be broadly applicable.
Our inducible expression system is based on conditional site-specific recombination by a split-Cre
recombinase (DiCre) that is only active in the presence of the inducer rapamycin (Rap). For inducible RNAi,
Rap treatment activates DiCre to invert a pair of tandemly duplicated RNAi target sequences into an
antiparallel orientation. Transcription of this inverted repeat generates a long double-stranded RNA stem-loop
that serves as a trigger for RNAi knockdown of the targeted mRNA. Specific Aim 1 has three components: 1)
We will generate a genome-scale plasmid library of random ~1 kb L. braziliensis genomic DNA fragments that
will serve as RNAi targeting sequences. 2) This plasmid library will be converted to a barcoded inducible stem-
loop RNAi library via a method developed in our lab called Strand Displacement Duplication (SDD); 3) The
inducible stem-loop RNAi library will be stably transfected into a DiCre-expressing L. braziliensis strain, using
CRISPR/Cas9 cleavage to improve library integration efficiency. Because the overall goal is to make the RNAi
library available as a resource for the community, we will validate the library by performing proof-of-principle
screens to identify drug resistance genes (Gain-of-Fitness) and pathways required for normal growth (Loss-of-
Fitness) (Specific Aim2). The representation of RNAi target sequences in library under various growth
conditions will be assessed via an adaptation of the barcode sequencing method (Bar-seq).
The L. braziliensis RNAi library platform will provide an innovative and much-needed new tool for high
throughput genetic screens in Leishmania. We anticipate that genome-scale RNAi screens will have a
sustained impact on the field by revealing mechanisms of drug action and resistance, and uncovering proteins
and pathways required for surviving any growth condition or lifecycle stage.

Public health relevance
Project Narrative Leishmania braziliensis parasites cause the disfiguring human diseases cutaneous and mucocutaneous leishmaniasis, for which the treatments are often toxic, ineffective, and are facing resistance. This proposal seeks to develop a versatile genetic tool that can be used to identify proteins that are important for parasite survival or that cause the parasites to resist drug treatments. The information gleaned from these studies could be useful in developing new drugs to treat these devastating diseases.